Mitigating Airborne PCB Emissions from Sediments with Black Carbon Materials and PCB-Degrading Biofilms

SUMMARY: PROJECT 5 – REMEDIATION IN SEDIMENTS
Polychlorinated biphenyls (PCBs) are commonly encountered organic chemical pollutants of concern at
Superfund sites, which are often found in river and lake sediments and in soils near areas of industrial and
commercial activity. The Iowa Superfund Research Program (ISRP) has shown that airborne PCB emissions
from open water associated with contaminated sediment sources could pose significant inhalation risk to
nearby populations. Project 5 research is based on the critical need to develop, evaluate, and demonstrate
innovative bioremediation approaches to disrupt the current flux of PCBs from sediments to air at Superfund
sites and minimize direct inhalation exposure to humans. Project 5’s central hypothesis is that black carbon
materials containing PCB-degrading biofilms will enhance aerobic biodegradation of LC-PCBs in contaminated
sediments, thereby reducing their emission into the atmosphere. Our hypothesis builds on discoveries from the
current funding cycle that bioaugmentation of suspended aerobic PCB-degrading bacteria into contaminated
sediment microcosms, equipped with passive air samplers, results in significantly decreased airborne emission
of several LC-PCBs. We also show that aerobic PCB-degrading bacteria form biofilms on black carbon
materials, indicating their potential as delivery vehicles for introducing PCB-degrading bacteria into sediments.
Guided by these findings, we will test our central hypothesis by: 1) identifying novel strategies for optimizing
performance and extending the activity of PCB-degrading biofilm-coated black carbon materials in
contaminated sediment microcosms, 2) determining important environmental factors and ecological
interactions driving airborne PCB bioremediation performance of biofilm-coated black carbon in mesocosm-
scale reactors, and 3) conducting a pilot-scale field demonstration of airborne PCB flux mitigation using biofilm-
coated black carbon material bioaugmentation. Our work will rely on the support of ISRP cores for synthesis
and analytical assessment of PCBs in study samples. The proposed research is innovative because the
relationship between the removal of LC-PCB congeners from sediments and PCB emissions has not been
studied. There are currently no developed or tested biotechnologies to decrease or prevent airborne PCB
emissions from sediments. Our project is relevant to the SRP mandates because we will develop advanced
methods to reduce the amount and toxicity of PCBs in the environment. Outcomes of this project will benefit
human health by reducing human exposure to airborne PCBs and realize economic benefits by demonstrating
breakthrough alternative PCB remediation approaches that minimize expensive and disruptive measures such
as dredging.

Public health relevance
NARRATIVE: PROJECT 5 – REMEDIATION IN SEDIMENTS Project 5 of the Iowa Superfund Research Program will identify innovative strategies for optimizing performance and extending the activity of PCB-degrading biofilm-coated black carbon materials in contaminated sediment microcosms, determine important environmental factors and ecological interactions driving biofilm-mediated airborne PCB bioremediation performance in mesocosm-scale reactors, and conduct a pilot-scale field demonstration of biofilm-coated black carbon material bioaugmentation. We will demonstrate that the best performing combinations of black carbon materials and microorganisms can effectively decrease airborne PCB emissions from contaminated sediments and thus lessen human exposure to PCBs by inhalation in communities located near Superfund sites. Therefore, the proposed research is pertinent to the goals of the Superfund Research Program by developing advanced methods to reduce the amount and toxicity of PCBs in the environment.